Understanding the Effects of the MISSION Act on VA's Specialty Care Referral Networks

Background: Recently, VA underwent two unprecedented disruptive changes that fundamentally altered how
care is delivered to Veterans. First, the VA MISSION Act was implemented in June 2019. Arguably the biggest
policy change in VA care delivery since the "Kizer revolution,” MISSION’s purpose is to improve Veteran
access to care, especially for services that have traditionally been resource-limited in VA due to geographic/
temporal barriers (e.g., specialty care). While VA healthcare systems were still in the early phases of adapting
to MISSION, the COVID pandemic spread rapidly across the world, resulting in a sudden and prolonged ramp-
down of elective outpatient care across the entire US healthcare system. VAMCs nationwide are independently
adapting to these disruptive changes in ways that directly impact Veterans’ health and experience.
Significance/Impact: Currently, we know little about MISSION’s early effects on where and how Veterans
access specialty care (as moderated by COVID-related disruptions), or factors influencing community care
referral. We also lack a clear understanding of how individual VAMCs are responding to these disruptive forces
in realigning organizational strategy/structure to optimize performance. Addressing these knowledge gaps is
critical to assessing the long-term impacts of MISSION and COVID on VA specialty care delivery and helping
VAMCs to tailor adaptation approaches to their local setting to optimize the health and experience of Veterans.
Innovation: Expansion of VA community care under the MISSION Act represents one of the largest natural
experiments in delivery transformation in any U.S. healthcare system in modern times. Thus, VA community
care expansion under MISSION offers an unparalleled opportunity to study the relationship between rapid
environmental change, organizational adaptation, and long-term performance. The unanticipated system
"reset" caused by COVID will only amplify and accelerate the adaptation process already underway.
Specific Aims: Aim 1: Examine the relationship between VAMC organizational/environmental characteristics
and longitudinal performance under MISSION/post-COVID, and the extent to which facility-level organizational
adaptation measurably impacts performance. Aim 2: Characterize variation in organizational adaptation by
high-performing tertiary VAMCs with different organizational/environmental characteristics. Aim 3: Explore how
the experience of Veterans with specialty care needs differs at high-performing VAMCs with distinct
organizational adaptation approaches.
Methodology: In Aim 1a, using a longitudinal pre-/post- comparison analysis, we will examine the relationship
between VAMC organizational/environmental characteristics and longitudinal performance under
MISSION/post-COVID, including measures of access, care coordination, and community care referral. In Aim
1b, using a difference-in-differences approach, we will leverage differences in financial incentives between
VAMCs to empirically assess the effect of VAMC organizational adaptation on longitudinal rates of VA
community care referral and other outcomes. In Aim 2, we will interview leadership at 12 high-performing Level
1 VAMCs with varying organizational/environmental attributes to characterize variation in adaptation
approaches under MISSION/post-COVID. In Aim 3, we will explore how VAMC organizational adaptation
impacts Veterans’ specialty care experience through qualitative interviews of 48 Veterans at select Aim 2 sites.
Implementation/Next Steps: This study will provide critical information about where and how Veterans access
specialty care under MISSION/post-COVID, how high-performing tertiary VAMCs with different organizational/
environmental characteristics are adapting to enhance specialty care delivery under MISSION/post-COVID,
and how variation in these adaptation approaches affects the Veteran experience of care. Grant products will
provide vital information to VHA leaders about how tertiary VAMCs with unique facility-level characteristics can
best adapt their organizational approaches to optimize performance and enhance the Veteran care experience.

Public health relevance
How healthcare organizations adapt in response to disruptive change has critical implications for patients. VA recently underwent two unprecedented disruptive changes that fundamentally altered the way in which care is delivered to Veterans. First, expanded community care access under the MISSION Act was implemented in June 2019, representing the biggest policy change in VA care delivery since the "Kizer revolution.” While VA healthcare systems were in the early phases of adapting to MISSION, the COVID-19 pandemic spread rapidly across the world, resulting in a sudden and prolonged ramp-down of elective outpatient care across the entire healthcare system. Our proposed research will leverage this rare combination of events to provide important insights into how large, complex health systems such as VA adapt to manage the health of a population in the face of disruptive forces, the relationship between these adaptation approaches and environmental and organizational characteristics, and their impact on specialty care access and the Veteran experience.